The role of Salmonella Typhi virulence factors in systemic dissemination

PROJECT SUMMARY
Salmonella enterica serovar Typhi (S. Typhi) is the causative agent of the systemic illness known as
typhoid fever that affects 21 million people each year resulting in an estimated 200,000 deaths. Unlike other
Salmonella serovars, S. Typhi is restricted to the human host where it causes a chronic systemic infection
characterized by fever and flu-like symptoms. Due to the strict host-specificity of the bacteria, the mouse models
available to study typhoid fever are limited to costly humanized mice or the use of the related bacterium
Salmonella enterica serovar Typhimurium (S. Typhimurium). While S. Typhimurium and S. Typhi share 89% of
their genomes, both serovars contain unique genes with over 600 S. Typhi specific genes, highlighting one of
the limitations of using S. Typhimurium to model typhoid fever. Furthermore, in the humanized mouse model,
mice are only susceptible to S. Typhi infection through parenteral routes (intraperitoneal or intravenous). For
these reasons there is limited knowledge on how S. Typhi uses its virulence factors to invade the gastrointestinal
tract and disseminate to systemic sites.
Our preliminary results characterize a novel mouse model of typhoid fever in which mice are permissive
to S. Typhi infection through a more natural, oral route. This important advancement allows research into the
mechanisms of S. Typhi-specific invasion and dissemination from the gastrointestinal tract to be performed. We
propose that S. Typhi uses its invasion associated type III secretion system-1 (T3SS-1) and/or flagella to invade
the gastrointestinal epithelium and then evades host immune detection via the virulence polysaccharide capsule,
Vi. To test this hypothesis, we will combine techniques such as bacterial genetics, antibody mediated
neutralization of select cell types, and flow cytometry to assess the host immune response. The proposed
research will generate robust and informative information on the mechanism of S. Typhi invasion that can help
direct future research on typhoid fever treatment and vaccine development.

Public health relevance
PROJECT NARRATIVE Salmonella enterica serovar Typhi (S. Typhi) is a human-specific pathogen that causes the systemic illness known as typhoid fever, affecting 21 million people each year and resulting in an estimated 200,000 deaths. As a human-restricted pathogen, there has not been an effective mouse model to study the mechanisms of S. Typhi dissemination from the gastrointestinal tract following oral infection. This proposal aims to utilize a newly characterized mouse model of oral S. Typhi infection to investigate the role of key virulence factors in dissemination from the gastrointestinal tract.